Combinations of Receptor-Targeted Alpha Radionuclide Therapy and Immune Checkpoint Inhibitors for Melanoma Treatment

ABSTRACT
Malignant melanoma is the most lethal form of skin cancer with an increasing incidence in the United
States. Unfortunately, no curative treatment exists for metastatic melanoma. Despite the significant advances
of molecularly targeted treatments (BRAF-, CTLA-4- and PD-1-targeted therapies) in treating metastatic
melanoma over the past decade, the 5-year survival is only 35% for metastatic melanoma patients. Thus, there
is an urgent need to develop alternative treatment strategies for metastatic melanoma.
Melanocortine-1 receptor (MC1R) is a distinct molecular target due to its high expression in >80% of
melanotic and amelanotic human metastatic melanoma. Our remarkable first-in-human results clearly
demonstrate the feasibility of using MC1R-targeted 68Ga-DOTA-GGNle-CycMSHhex for human melanoma
imaging. Recently, we have identified DOTA-GGNle-CycMSHhex(KD) peptide with 0.12 nM MC1R binding
affinity which is dramatically improved by 8.3-fold as compared to DOTA-GGNle-CycMSHhex. Moreover, the
replacement of -GG- with 8-Aminooctanoic acid (-Aoc-) linker further improves the MC1R binding affinity of
DOTA-AocNle-CycMSHhex(KD) peptide by 3.8-fold as compared to DOTA-GGNle-CycMSHhex(KD). Thus, we
propose to develop novel theranostic 203Pb/212Pb-DOTA-Linker-Nle-CycMSHhex(KD) peptides for imaging-
guided MC1R-targeted alpha radionuclide therapy (MC1R-TART), and combine them with immune checkpoint
inhibitors (ICIs) for melanoma treatment in this project. We hypothesize that novel theranostic 203Pb/212Pb-
DOTA-Linker-Nle-CycMSHhex(KD) peptides can be used for imaging-guided MC1R-TART, and the
combinations of MC1R-TART and ICIs can treat melanoma more effectively than MC1R-TART only.
The objective of this project is to develop novel theranostic 203Pb/212Pb-DOTA-Linker-Nle-CycMSHhex(KD)
peptides imaging-guided MC1R-TART, and combine MC1R-TART with ICIs for melanoma treatment. Our
awarded US patents clearly demonstrate the originality and novelty of this project. Our positive preliminary
results strongly support our hypothesis and research design. Importantly, we have assembled a strong
research team with established expertise that is uniquely suited to carry out this exciting translational project.
The positive results of this project will demonstrate the feasibility and efficacy of combining MC1R-TART and
ICIs for melanoma treatment, and provide a new insight into the design of novel treatments for metastatic
melanoma. The success of this project will provide clinicians a novel valuable imaging tool (203Pb-peptide) to
identify MC1R-positive patients who will benefit from the treatments, determine patient-specific dosimetry for
safe and efficacious doses, and monitor patients’ responses to MC1R-TART and ICIs treatments. The success
of this project will pave the way for evaluating this novel treatment in future FDA-approved clinical trials,
provide patients with personalized diagnoses and treatments, enhancing the opportunity for cure to metastatic
melanoma patients.

Public health relevance
NARRATIVE We propose to develop novel theranostic 203Pb/212Pb-DOTA-Linker-Nle-CycMSHhex(KD) peptides for imaging-guided melanocortin-1 receptor-targeted alpha radionuclide therapy (MC1R-TART) and then combine MC1R-TART with immune checkpoint inhibitors (ICIs) for melanoma treatment, enhancing the opportunity for cure to metastatic melanoma patients.